Synthesis of the Multi-Modality High Resolution 3-D Atlas of Human Lung

Project Summary/Abstract
Organ Specific Project Component
Multi-Scale Multi-Modality High Resolution Mapping of the Adult Human Lung
Maintaining normal lung function and inducing repair of damaged lung can be markedly improved if we better
understand the cellular and molecular complexities of the organ. Technical and analytical advances now make
it possible to gain detailed access to previously hidden fundamentals of lung biology by generating high
resolution, single cell and subcellular, biomolecular maps coalesced into an atlas of the human respiratory
system. It is the goal of HuBMAP and specifically of this Lung TMC to generate interactive, searchable, cell type
and subtype annotated maps and tabular data representing transcriptome, proteome, metabolome, and select
posttranslational modifications (PTMs) of healthy lung. Ultimate deliverable will be integration of these maps into
a reference atlas of healthy lung to which diseased lung can be compared. Such a biomolecular atlas with multi-
scale, 3D spatial resolution will be truly transformative for human pulmonary biology with ramifications also for
understanding the immune and vascular systems throughout the body. Building upon our successful HuBMAP
Phase 1 engagement, our tissue mapping strategy brings multiple strengths including 1) an established, robust,
tissue biorepository, 2) well oriented tissue samples representing the entire human lung with focus on regions of
interest, 3) snRNAseq/ATACseq dual-omic sequencing and mass spectroscopy based bulk metabolomics to
provide basis for deconvolution of, 4) novel spatial transcriptomic methods, 5) spatial highly-multiplexed chemical
and immunofluorescent microscopy, 5) a suite of unbiased mass spectrometry, stimulated Raman spectroscopy
and advanced microscopy technologies, all combined in such a way to enable spatially resolved co-localized 2D
and 3D mapping of gene expression, metabolites, lipids, proteins, and protein modifications across lung tissues
with single-cell or near single-cell resolution. We will include assays on 40 diverse donor lungs creating tissue
microarrays to enhance assay throughput. We envision achieving an unprecedented level of biomolecular
mapping of the trachea, extra and intra-pulmonary bronchi with bronchial artery and lymphatic systems, several
levels of bronchioles with focus on broncho-vascular bundles and terminal-respiratory-alveolar duct transition
regions as well as alveolar and pleural regions. Working with the HuBMAP HIVE and our DAC, our achievable
goal will be, by microdissection, serial section reconstruction and 3D imaging of thick sections, a Multi-Scale
Multimodality High Resolution 3-D and Tabular Atlas of the Adult Human Lung.